Engaging Low-Income Urban Residents in Prioritizing Interventions for Health

The goal of this project is to explore the possibility of designing public policies aimed at improving the health of urban low-income populations in the US. Toward this end, this project will engage health policy experts and low-income residents in an exploratory exercise aimed at designing an affordable, evidence-based intervention program targeted at addressing socio-economic factors and reducing health disparities among low income residents of Washington, DC. A three step process will be carried out: [unreadable] [unreadable] 1. Identification of candidate interventions that have been shown to ameliorate the socio-economic determinants of health, through literature review and consultation with experts; [unreadable] 2. Consideration of a reasonable per capita expenditure for the purpose; [unreadable] 3. Engagement of low-income residents to ascertain their priorities for publicly funding the proposed interventions within the assigned budget. [unreadable] [unreadable] Several hundred low-income adults recruited from clinical and community settings will participate in this engagement process through small group exercises in which a facilitated discussion will take place using a previously tested group decision tool, REACH (Reaching Economic Alternatives that Contribute to Health). Data pertaining to participants socio-demographic characteristics, attitudes toward health, and preferences for possible interventions will be collected anonymously. Group discussions will be audio-taped. Data will be analyzed quantitatively and qualitatively to determine preferences for various interventions and their association with socio-demographic characteristics. Participants will be financially compensated for their participation. [unreadable] [unreadable] Given the anonymous nature of the data collection, we anticipate no risks other than those entailed in discussion of poor health outcomes associated with lack of insurance and low income. Participants may benefit from learning about factors that improve health status.[unreadable] [unreadable] Study results will yield information about benefits that are of utmost priority to low income urban residents. This is unique information that may contribute to efforts to find affordable strategies for ameliorating the socio-economic determinants of health for low-income urban population in the US.